How does myelin plasticity influence neural circuit dynamics required for long-term memories?

PROJECT SUMMARY
To retain new memories over long periods of time, the brain must be able to change in response to
learning and then stabilize those changes to store long-term memories. However, the cellular mechanisms
that enable long-term memory recall remain incompletely understood. Intriguingly, recent evidence suggests
that myelin, the lipid-rich substance produced by glial cells known as oligodendrocytes, is critical for long-
term memory recall. Myelin, previously thought to be static and stable after development, is critical for
nervous system function; its primary role is to increase the conduction velocity of electrical signaling by
neurons. In the adult brain, learning can induce the formation of new myelinating oligodendrocytes, known
as oligodendrogenesis. The new myelin sheaths created by oligodendrogenesis are critical for the recall of
long-term memories.
However, how myelin is precisely modulated to regulate the neural activity underlying long-
term memory storage remains an open question. To address this, I use an active avoidance paradigm in
which mice learn to associate a light cue with a mild footshock and escape by shuttling to avoid footshock.
The trial-based structure, the ability to compare correct and incorrect trials, and the greater diversity of
behavioral readouts enable precise correlation between neural features and behavior. Furthermore, the
specificity of these readouts can help uncover the precise circuits that are impacted by new myelin formation.
Using the active avoidance, I will 1) identify which neurons become myelinated in the medial prefrontal
cortex after avoidance learning using two-photon microscopy and 2) determine how oligodendrogenesis
influences synchronization in the cortical-hippocampal-amygdala network during avoidance memory recall.
Together, I will uncover how learning shapes myelination and how this myelin plasticity influences neural
dynamics during long-term memory. These studies will shed light on underexplored, non-neuronal plasticity
mechanisms that shape neural dynamics and have broad implications for our understanding of how the brain
changes after learning.
I will be conducting these experiments in Dr. Mazen Kheirbek’s laboratory, where all the techniques
necessary for my project have been set up. The Kheirbek laboratory is located at the University of California,
San Francisco, a world-renowned biomedical research facility. With the support of Dr. Kheirbek, co-sponsor Dr.
Vikaas Sohal, and additional support from Dr. Jonah Chan, I am perfectly positioned to complete the described
project. My postdoctoral work will enable me to achieve my ultimate career goal of running an independent
academic laboratory studying how neuron-glia interactions influence neural circuit dynamics and behavior.

Public health relevance
PROJECT NARRATIVE The research project described in this proposal seeks to understand how myelin plasticity impacts neural circuit dynamics during long-term memory recall. Using cutting edge approaches, I will identify the neural populations that become myelinated after an aversive experience, and how the formation of new myelin impacts synchronization across a cortical-hippocampal-amygdala network during long-term memory recall. These findings provide insight into how non-neuronal cells can impact neural circuit dynamics to support long-term memory recall.